Estimating Mediation and Moderation Effects in HIV Care Continuum Intervention Trials for People who Use Drugs

PROJECT SUMMARY
The overall goal of this study is to conduct secondary analyses of available randomized controlled trial (RCT)
intervention data to gain actionable knowledge about how to improve HIV care continuum (HIV-CC) outcomes
among people living with HIV who use drugs (PLWHUD). Specifically, we will use available data from four
different RCTs to their full potential by analyzing mediators and moderators of efficacy that were not tested during
the original outcome analysis of the respective trials. The RCTs tested different HIV-CC interventions for
PLWHUD: 1) ARCS, which tested a community and individual level stigma reduction intervention for people living
with HIV who inject drugs in Vietnam; 2) HOPE, which tested patient navigation and contingency management
among hospital patients in the U.S. living with HIV with co-occurring substance use disorder; 3) LINC, which
tested a strengths-based patient navigation intervention among hospital patients in Russia living with HIV with
co-occurring injection drug use; and 4) HPTN 074, a HIV Prevention Trials Network RCT that tested an
intervention involving systems navigation, psychosocial counseling, and ART initiation among people living with
HIV who inject drugs in Vietnam, Indonesia, and Ukraine. Specific aims include: 1) Determine how and for whom
HIV-CC interventions improve biological outcomes (viral suppression, CD4, mortality) among PLWHUD. For this
aim we will test concordant hypotheses across all four trials about theory-based mediators and substance use
mediators, as well as moderators, and conditional process models (that simultaneously test mediators and
moderators in a single model); 2) Examine which specific mediators primarily affect HIV-CC outcomes among
subgroups of PLWHUD using newer causal mediation analysis to strengthen causal inference; and 3) We will
review our evidence to date to disseminate how HIV behavioral interventionists can meet improved standards
for complete evaluations in RCTs (i.e., test mediators plus moderators). The research is led by experts in HIV
prevention and care among vulnerable populations, including people who use drugs, and experts in advanced
mediation and moderation analysis. The study activities and deliverables will also be informed by a Scientific
Advisory Committee comprised of the original Principal Investigators from each of the four trials, as well as an
original Co-Investigator from each of the trials. These individuals include some of the leading experts in HIV-CC
engagement for people who use drugs and will be instrumental to informing the analyses and interpretation of
results. The research builds on our previous NIH R01-funded research that demonstrated how mediation and
moderation analyses help to shed new light on efficacious and non-efficacious results found in HIV prevention
RCTs. Moving beyond our previous research, in the current study we will disseminate accessible tools to the
HIV field that should improve our evaluation of interventions, and that will accelerate the impact of each future
RCT. Last, by analyzing drug use-related variables we gain valuable insight into the role of drug use in the
efficacy of HIV-CC interventions for PLWHUD, a critical population to support in order to end the HIV epidemic.

Public health relevance
PROJECT NARRATIVE This study leverages available data from four randomized controlled trials (RCTs) that tested interventions to promote HIV care continuum engagement among some of the most socially and medically vulnerable populations in the world, specifically people living with HIV with co-occurring drug use in the U.S., Asia, and Eastern Europe. We will maximize the data to their full potential by analyzing mediators and moderators of efficacy in affecting biological HIV care continuum outcomes (viral suppression, CD4, mortality). The study will improve evaluation methods and measures in future RCTs testing interventions among vulnerable populations.